Administrative Core

The Administrative Core will provide overall management of the COBRE program. The specific goals of the Administrative Core are as follows: 1) Provide secretarial and administrative support to the COBRE program; 2) Facilitate scientific interactions and collaborations; 3) Facilitate effective mentoring of promising junior investigators and recruitment of center investigators to the COBRE program; 4) Administer Pilot Project Grant Program; 5) Increase the visibility of the Oklahoma Center for Respiratory and Infectious Diseases; and 6) Coordinate COBRE program evaluation.